Optogenetic and chemogenetic manipulations of striatal output pathways for seizure control

Project Abstract
Deep brain stimulation for epilepsy is growing in use, and offers promise to patients for whom other
treatments fail. Thus, identifying new targets for stimulation is of considerable clinical and translational interest.
The basal ganglia (BG), which have been explored extensively for stimulation in movement disorders, also may
be attractive targets for epilepsy. Preclincial studies show that modulating activity in BG nuclei such as the
striatum and substantia nigra pars reticulata (SNpr) can potently suppress experimental seizures in acute models
of epilepsy. However, the network mechanisms underlying this effect, and the degree to which this translates
into models of chronic epilepsy remain unknown.
This NRSA F30 proposal requests four years of support. During years 1 and 2, I plan to complete my
doctoral thesis. The thesis will encompass the two aims presented in the following research plan that have been
heavily updated to reflect my research progress since the submission of the original proposal.
In aim 1, I will test the hypothesis that on-demand optogenetic silencing of the SNpr will suppress
spontaneous seizures in chronically epileptic rats. In parallel, I will test the hypothesis that on-demand activation
of the striatum will produce an equivalent suppression of spontaneous seizures. While these manipulations are
well-studied in acute seizure models, these studies would be the first to evaluate the anticonvulsant potential of
these regions in chronic epilepsy. During the course of this aim, I will learn the status epilepticus model of chronic
epilepsy in rats and the set up of self-contained, automated systems to monitor their seizure activity.
In aim 2, I will use fiber photometry to test the hypothesis that seizure activity progressively and
differentially engages basal ganglia output pathways. I will also test the hypothesis that optogenetic
manipulations that counteract pathological recruitment of striatal pathways will suppress seizures. The training
in this aim includes learning the technical aspects of fiber photometry as well as coding and data analysis
methods.
Throughout the course of my doctoral research, I will continue to be trained in physiological and
histological methods as well as general skills and career development. After I complete my thesis defense, I will
complete my pre-doctoral medical training during years 3 and 4 of the fellowship period. Clinical training follows
a standardized institutional curriculum. After this period of joint-degree training, I plan to apply to combined
residency/fellowship tracks in physician-scientist training programs in neurology/epileptology.
In sum, during the proposed fellowship period, I will gain expertise in cutting-edge techniques in
neurophysiology concurrent with training in intellectual and practical career development. The work proposed
will benefit the field by determining mechanisms of seizure propagation and restraint via basal ganglia nodes
while also testing them as candidates for the management of chronic spontaneous epilepsies.

Public health relevance
Project Narrative Deep brain stimulation is of growing use in epilepsy, and identifying new targets for stimulation is expected to improve outcomes for patients. Here, I will determine if stimulation and silencing of the basal ganglia, a region that integrates inputs from many brain regions, suppresses seizures in a rat model of chronic epilepsy. In parallel, I will determine the circuit mechanism by which the basal ganglia suppress acute seizures through in vivo recording of neuronal activity.